Neural and Behavioral Mechanisms of Angry Hostility in Depression

ABSTRACT
Despite the fact that multiple different treatments for depression have been available for decades, the global
burden of the illness has grown steadily. Depression is now one of the leading causes of disability worldwide.
Current treatment strategies for depression remain largely trial-and-error, and fewer than 40% of patients
respond to a given treatment and sustain that response for a year, even when treatment is continued. A central
barrier to improving these outcomes is the need to characterize better phenotypes of depressive illness that are
more closely aligned to modifiable neurobiological targets than are current symptom constellations and
diagnostic codes. Findings from our group, and from others, suggest that one such phenotype involves the
propensity to experience anger, hostility, and irritability following negative experiences and to respond in an
aggressive, overly hostile manner (hereafter denoted Angry Hostility). Our preliminary data suggest that the
Angry Hostility phenotype is associated with a particular pattern of altered functioning in neural regions that
support emotion processing and emotion regulation. Furthermore, Angry Hostility appears to be strongly
associated with hostile, aggressive behaviors following provocation and with real-world interpersonal and work-
functioning impairments that can exacerbate depressive symptoms. The primary goal of this project is to test a
novel model through which higher levels of Angry Hostility among adults with depression are associated with
specific patterns of abnormal neural function and behavior, leading to poor functional outcomes and future
symptoms. To achieve these goals, 150 adults (18-45 years old) with at least mild symptoms of depression will
be recruited, as will 100 demographically matched, psychiatrically healthy individuals. Participants will complete
clinical, neuroimaging, and laboratory behavioral assessments, as well as 4-, 8-, and 12-month follow-up
assessments and four 10-day ecological momentary assessment protocols. The project will examine 1) whether
Angry Hostility is associated with abnormal neural function in emotion processing and emotion regulation
regions; 2) whether Angry Hostility is associated with aggressive behaviors in the laboratory and in real-world
settings; and 3) whether abnormalities in a-priori neural systems and behaviors prospectively predict poorer real-
world functioning and psychiatric symptoms over the 12-month follow-up. The aims of the project match well with
the strategic goals of the National Institute of Mental Health. Moreover, the results of this study have the potential
to describe the neurobiological bases, behavioral mechanisms, and real-world consequences of elevated Angry
Hostility among adults with depression. Future work will aim to develop personalized treatments to target the
neural mechanisms identified in this study in order to reduce symptoms and improve functional outcomes for
adults with depression who have higher levels of Angry Hostility.

Public health relevance
PROJECT NARRATIVE This project seeks to describe the neurobiological and behavioral processes underlying a critical dimensional phenotype of depressive illness, Angry Hostility, which refers to the tendency to experience anger, hostility, and irritability following negative experiences and to respond in an aggressive, overly hostile manner. We will examine whether this phenotype is associated with specific patterns of abnormal brain function and behavior in emotional contexts. Findings will help us to identify neurobiological targets that we could use to develop more effective, individually tailored treatments for adults with depression who have high levels of Angry Hostility.